The Detection, Quantification, and Management of Ventilator Dyssynchrony

Project Summary/Abstract
Despite significant advances in ventilator management, mortality from the acute respiratory distress syn-
drome (ARDS) remains unacceptably high. Mechanical ventilation with large tidal volume, high pressure ven-
tilation, and repeated alveolar collapse can injure the lung, called ventilator induced lung injury (VILI). Defined
as the inappropriate timing and delivery of a breath in response to a patient effort, ventilator dyssynchrony (VD)
may potentiate VILI. This proposal outlines a 5-year training programing including mentoring, formal didactics,
and practical research experiences which positions Dr. Sottile for a successful clinical research career examining
ventilator dyssynchrony (VD), its impact on ventilator induced lung injury (VILI), and its optimal management.
An integrated curriculum will optimize an automated VD detection algorithm, delineate which types of VD
are deleterious, and determine the ideal ventilator and sedation strategies to minimize VD and improve
patient outcomes. This experience will provide Dr. Sottile with the necessary tools to be a leader in signal
analysis, ventilator dyssynchrony, advanced mathematical modeling, and critical care research. This program will
consist of formal mentoring from four renowned experts in machine learning, mechanical ventilation, critical care
research, and modeling of dynamic systems. In addition, coursework in clinical sciences, machine learning, and
advanced mathematical modeling will build the theoretical foundation to apply these techniques. This structured
curriculum will help Dr. Sottile gain expertise in the computerized detection of VD from real-time ventilator data,
the pathophysiology of VD, and the modeling of complex, temporally dynamic, biological systems.
The formal curriculum will coincide with three practical experiences. First, Dr. Sottile will optimize his already
developed VD identification algorithm to detect additional types of VD that may be injurious to the lung. Second,
he will identify which types of VD are associated with deleterious ventilator mechanics. Finally, he will deter-
mine the personalized ventilator and sedation strategies to minimize VD, VILI, and the negative consequences of
over sedation using linear optimization and lagged linear correlation to account for the dynamic nature of patient
physiology.
The result of the proposed studies will develop a computerized algorithm to detect seven types of VD,
identify which types of VD are most likely to propagate VILI, and determine the optimal ventilator and
sedation strategies to improve individual patient outcomes. This will leave Dr. Sottile and the study team
positioned to conduct a randomized clinical trial comparing computer-predicted individualized ventilator and se-
dation strategies compared to the current standard of care. If successful, this will potentially to revolutionize the
use of mechanical ventilation by tailoring evidenced-based therapies to the individual patient.

Public health relevance
Project Narrative Despite over 50 years of research, the acute respiratory distress syndrome (ARDS) accounts of over 10% of ICU admissions. Despite current treatment strategies focused on reducing ventilator induced lung injury through low tidal volume ventilation or prone position, mortality remains over 30%. This proposal seeks to understand how patient-ventilator interactions may propagate lung injury and will determine optimal treatment strategies to improve patient- ventilator interactions, decrease lung injury, and improve patient outcomes.